Regulation of mitochondrial fatty acid synthesis in the control of mitochondrial metabolism.

Project Summary
Lipids are important cellular macromolecules that form membranes, are a major form of energy storage, play
crucial roles in cell signaling, and are frequently dysregulated in disease. Cells obtain lipids in two main ways:
either through uptake from exogenous sources or else via synthesis from acetyl-CoA in the cytoplasm by Fatty
Acid Synthase (FASN). However, cells have evolutionarily maintained a second, completely distinct fatty acid
synthesis pathway in the mitochondria (mtFAS).
Mitochondria are well known as the “powerhouse of the cell.” In direct contrast to this well-known function,
the mtFAS pathway uses acetyl-CoA to build fatty acids instead of breaking them down. Why mitochondria
harbor a pathway that builds fatty acids, especially given that mitochondria take up lipids from other
areas of the cell, is incompletely understood. In fact, mtFAS is so understudied that the genes encoding
several steps in the pathway are still unannotated. The major goal of my research group is to define the basic
biology of the mtFAS pathway.
I previously defined a mechanism whereby mtFAS coordinates three major functions of the mitochondria: the
TCA cycle, electron transport chain assembly, and iron-sulfur cluster biogenesis. We hypothesize that this
coordinating function of mtFAS provides cells with a means to monitor mitochondrial acetyl-CoA – the substrate
of the pathway – and to adjust mitochondrial metabolism accordingly. The mechanisms that regulate this nutrient
sensing function and mtFAS activity in general are undescribed. The studies planned in this proposal will address
crucial gaps in our understanding of how genes and metabolites control mtFAS pathway activity. We will also
explore cell-type specificity of mtFAS pathway action, and the role of mtFAS in cellular differentiation signaling
and cell fate decisions. Defining how mtFAS regulates mitochondrial function in response to changes in
metabolite availability will rewrite the field’s working model of how mitochondria sense nutrients and
adapt to changing nutritional environments.
I am well suited to achieve these goals due to my expertise in mtFAS pathway function and my prior research
experience in mitochondrial biology, which lies at the intersection of bioenergetics, cell signaling, and metabolic
regulation. Successful completion of these studies will place me and my trainees at the forefront of the field of
mitochondrial metabolism, and well-position my laboratory for long-term success.

Public health relevance
Project Narrative The mitochondrial fatty acid synthesis (mtFAS) pathway is a major rheostat of mitochondrial function, but the pathway is poorly defined in mammals and almost nothing is known about its regulation. Our preliminary data in yeast and cultured cells support a model in which mtFAS activity responds to changes in nutrient availability in the mitochondria, but many questions remain, including which fuels drive mtFAS, and how the pathway acts to direct metabolism in tissues with disparate mitochondrial functions. The experiments outlined in this proposal will mechanistically characterize the basic biology of mtFAS pathway function and regulation in mammalian systems.